Plasma neuronal-derived exosomes are biomarkers of HIV cognitive impairment

Cognitive impairment in chronic well-controlled HIV infection continues to affect from 30%-60%
of individuals. Mechanisms are still unknown but probably associated with continued
neuroinflammation. Biomarkers for cognitive impairment have been inconsistent although
neuroimaging has emerged as a possibility. Unfortunately, imaging is expensive with limited
access. Exosomes are small microvesicles shed from most all cells under normal and pathologic
conditions. The cellular cargo packaged into exosomes can represent the state of the parent cell.
We have isolated neuron-derived exosomes (NDE) in plasma using a 2-step isolation procedure
and a cell surface neuron specific antibody. We have shown in a recently completed R21 using
mass spectroscopy that NDE are rich in over 50 neuronal proteins. In addition, using proximity
extension analysis (PEA) for neurology biomarkers, we identified an additional 28 proteins that
were present. At least 7 proteins were statistically significantly differentially expressed in HIV
infection alone, neurocognitive impairment in HIV+ women versus men and 1 protein that was
significantly correlated with age and impairment. Several NDE proteins correlate with cognitive
domains and several differentiate HIV cognitive impairment from Alzheimer’s disease. Our
overall hypothesis is that NDE can be used to diagnose cognitive impairment in HIV infection
and that men and women have different proteins in NDE that will influence diagnosis and
treatment. We further plan to differentiate mild cognitive impairment with that associated with a
pre-Alzheimer’s mild cognitive impairment (MCI) diagnosis. To test this hypothesis, we propose
the following Specific Aims: (1) Select and verify a set of neuronal exosome proteins that predict
and diagnose HIV cognitive impairment with aging in women and men, (2) Determine whether
neuronal exosome cargo can differentiate HIV-associated cognitive impairment from mild
MCI/Alzheimer’s disease (3) Correlate HIV NDE protein targets and cognitive domains
associated with neuroimaging markers of injury and (4) Establish a rapid ultrasensitive assay
using verified neuronal exosome target proteins for diagnosis of HIV cognitive impairment in a
longitudinal cohort. We will utilize a multidisciplinary approach that includes basic research of
protein targets correlated with cognitive domains and clinical diagnosis using neuroimaging
correlation with selected biomarker proteins. These results will have major impact on treatment
and cure of HIV in the brain as fluid biomarkers are discovered and the health of the neuron can
be assessed in “real time.”

Public health relevance
A major goal in HIV infection and for the NIH is to improve diagnosis of ongoing cognitive impairment as well as monitor brain health with the advent of new therapies and cure tactics. This proposal demonstrates that extracellular vesicles shed from neurons into the peripheral blood have newly discovered proteins that correlate with cognitive impairment and differ in men versus women. We will correlate these biomarkers with neuroimaging and develop a panel of proteins for prognosis and diagnosis of neurocognitive impairment.